Evolution of Cryptococcus neoformans Strains from Patients with HIV/AIDS

ABSTRACT
Cryptococcus neoformans is the most common and deadly fungal pathogen of the central nervous system in
HIV/AIDS patients worldwide, causing hundreds of thousands of cryptococcal meningitis (CM) cases each year.
With the profound loss of CD4+ immune cells and weakened blood-brain barrier, C. neoformans spreads
efficiently from the lung to the brain and is difficult to treat. Clinicians lack the critical diagnostic information to
identify highly pathogenic yeast isolates and successfully treat their patients because the factors that influence
CM disease severity in humans are largely unknown – and no new antifungal agents have been developed in
over 25 years. Preliminary data show clearly that C. neoformans isolates differ in their pathogenicity, and isolates
from clinical – but not environmental – settings are associated with high CM disease severity in animal models.
We will address the critical need to determine the underlying mechanisms responsible for C. neoformans
pathogenicity, by defining and characterizing the evolving population of diverse isolates in both environmental
and clinical settings. Our comprehensive platform of phenotyping, comparative genomics, and genome-wide
association studies will enable genotype-to-phenotype analyses, focusing on virulence traits: (1) a
collection/repository of 3000+ global C. neoformans isolates with sequenced genomes; (2) a high-throughput
robotic system for large-scale phenotypic analyses; (3) phenotypic arraying for in vivo relevant phenotypes that
can be linked to genomic data and specific clinical outcomes; (4) robust animal models (i.e. zebrafish for
screening large numbers of yeast isolates; murine for brain and lung disease assessment through yeast census
and immune responses; and rabbit for CNS disease validation); (5) a genetics system that facilitates multiple
analyses and genetic crosses for future QTL-based studies, as well as robust genetic and molecular biology
methodologies to dial down on targeted genes of interest; (6) metadata on clinical de-identified human data, as
well as on isolates for yeast burden during infection and impact on mortality; and (7) defined in vivo yeast
transcriptomics from isolates from human CSF to link in vitro and in vivo animal studies with human disease.
Aim 1 will determine the genetic variants associated with virulence by systematic, comparative analyses of
clinical and environmental isolates. This will answer the question of what turns an environmental strain that does
not cause disease into a clinical strain. Aim 2 will identify and validate genetic variants associated with aggressive
clinical isolates that enhance human infection. This will address the question of what causes increased
aggressiveness in a clinical strain. These components will identify genes critical for C. neoformans production of
aggressive disease and for in vivo survival/fitness in animal models and humans. enable us to link important
disease traits with specific genomic features, in order to predict strain virulence based on genotype. Our data
should lead to development of new therapeutic strategies that reduce disease severity and improve outcomes
in HIV/AIDS patients. Finally, this study will create a substantial infrastructure addition to a library of well-
characterized wild-type strains for use by the entire cryptococcal community for future pathobiology work.

Public health relevance
PUBLIC HEALTH RELEVANCE The yeast Cryptococcus neoformans causes cryptococcal meningitis (CM), a difficult-to-treat, deadly fungal disease with high mortality that is a major comorbidity of HIV/AIDS. This project will utilize a comprehensive platform of phenotyping, comparative genomics, and genome-wide association studies to define and characterize the evolving population of diverse isolates in environmental and clinical settings. By identifying the factors that influence CM disease severity in humans, our data should lead to development of therapeutic strategies that reduce disease severity and improve outcomes for HIV/AIDS patients.